Autumn Immunology Conference

This proposal requests 2 years of support for the Autumn Immunology Conference (AIC), an annual gathering
of immunologists at the Marriott Downtown Magnificent Mile hotel in Chicago, IL. Year 1 will support the 50th
annual AIC on November 18-21, 2022 and Year 2 will support the 51st annual meeting to be held November 17-
20, 2023. The purpose of AIC is to foster communication and collaboration among immunologists, particularly
those located in the upper Midwest region of the US. Chicago is an exciting destination, and within driving
distance for many midwestern academic institutions that are home to numerous NIAID-funded investigators.
Since its inception in 1972, AIC continues to be very highly regarded and has a fiercely loyal group of regular
attendees from the Midwest, but it also attracts immunologists from around the US each year. The Specific Aims
of AIC are to: 1) disseminate new immunological research findings from top labs in the field, 2) provide a forum
for trainees to hone their presentation skills, and 3) increase interactions between a diverse group of scientists
interested in immunology research. The meeting starts with a “Meet the Speakers” event for trainees, a Keynote
speaker, and a welcome reception on Friday. Saturday & Sunday have similar structures: morning symposia,
then smaller themed workshops, followed by poster sessions. The meeting ends on Monday with just a morning
plenary session. Each year, three different topic areas are chosen for the morning symposia. For 2022, 6 female
& 6 male invited speakers will present talks on Transplantation, T Cell Development, & Autoimmunity; the 2023
topics will be chosen by the AIC Chair in consultation with the Executive Council (EC) at the spring planning
meeting. All accepted abstracts (typically ~250 from postdocs/grad students/undergrads) are invited to give a
10 min. talk during the afternoon workshops, followed by a 1 h poster presentation. AIC is organized by a
dedicated all-volunteer group of faculty that serve multi-year terms including the “leadership track” that consists
of a 4 year commitment to serve as the Workshop Coordinator, the Secretary, the Chair, and then the Past
Chair/Councilor. Since 1992, the EC has strived to maintain a gender balance amongst its members; we typically
rotate males and females to enter the leadership track such that the 2022 meeting will be chaired by Dr. Richard
DiPaolo (St. Louis Univ) and the 2023 meeting will be led by Dr. Kerry Empey (U. Pitt). Another unique feature
of AIC is the Undergraduate Workshop with a Careers in Immunology panel discussion and a table fair of PhD
programs in Immunology. AIC is truly a formative experience for trainees and this remains one of the most
positively evaluated aspects of the meeting. The volunteer EC works hard to solicit academic and corporate
donations so that we can keep the registration fee low, allowing as many trainees as possible to attend this
meeting. In fact, the registration fee is waived for any undergrad who presents an abstract. The 50th annual AIC
is significant because it also marks the 30th anniversary of the inception of our Wallace Diversity Fellows program,
which provides travel awards and networking opportunities to underrepresented minorities.

Public health relevance
This application requests funding to support the Autumn Immunology Conference, an annual gathering of scientists (primarily from the midwestern US) that is designed to facilitate the dissemination of new research results, to establish or strengthen collaborations between laboratories, and to serve as a platform for the development of young trainees in the field of immunology. Research in immunology is important for the public health mission of NIH and greatly impacts our ability to understand autoimmunity and allergy, to design effective vaccines to prevent infectious diseases, and to improve cancer immunotherapy regimens.